Elucidation of the chemical and biological roles of five-carbon metabolism

Project Summary
Our long-term goal is to decipher the multifaceted role of five-carbon (C5) metabolism in cellular physiology and
disease. Five-carbon metabolism derives from the central hub of the isoprenoid pathway, which is necessary for
an array of critical bioactivities, including cell membrane integrity (e.g., cholesterol), glycoprotein synthesis (e.g.,
the dolichols), steroid hormone signaling (e.g., androgens, estrogens, and cortisol), and mitochondrial health
(e.g., coenzyme Q). Human isoprenoids derive from the mevalonic acid (MVA) pathway, whereas many other
organisms utilize the methyl erythritol phosphate (MEP) pathway. The MVA and MEP pathways both converge
on the same two isomeric C5 metabolites, isopentenyl pyrophosphate (IPP) and dimethylallyl pyrophosphate
(DMAPP). Therefore, IPP and DMAPP are the central five-carbon precursors for all isoprenoids in all organisms.
Despite their importance, there are relatively few chemical and biological tools to directly study IPP and DMAPP
and little is understood about their independent biological activity, and metabolic fate beyond incorporation into
longer chain isoprenoids. Furthermore, no chemical probes or genetic tools have been developed to modulate
the activity of human isopentenyl pyrophosphate isomerase (IPPI), which is necessary to produce DMAPP and
maintain homeostasis of the C5 precursor pool. Levels of IPP and DMAPP are directly involved in cardiovascular
disease and IPPI has recently been implicated in the progression of Alzheimer’s, and the development disorders
Zellweger spectrum disorder and adrenoleukodystrophy. Extensive prior research efforts have focused on
developing inhibitors for enzymes in the MVA pathway, but human IPPI has not been explored. Similarly,
chemical tools developed for studying prenylation via the long-chain isoprenoids farnesyl pyrophosphate (C15)
and geranylgeranyl pyrophosphate (C20) are well-established, but tools and approaches for interrogating C5
prenylation are completely lacking. The collective lack of tools and approaches for studying C5 metabolism is
likely caused in part by the fact that IPP and DMAPP are cell impermeant and thus cannot be exogenously
delivered to cells. We recently addressed this key barrier through the development of cell-permeant analogs of
IPP and DMAPP and demonstrated their utility in human cancer cell lines and the model gram positive bacterium
Bacillus subtilis. Motivated by our recent progress and proof-of-principle preliminary results supporting the
research methodology, we will address unmet needs by: (1) creating the next generation cell-permeant C5
analogs and developing inhibitors and cellular tools targeting modulation of IPPI activity; (2) develop a high
throughput assay for the quantification of IPP and DMAPP in cellular experiments; and (3) Combine the
developed chemical biology tools with advanced analytical approaches to discover and characterize novel
metabolites and biological functions of C5 metabolism. Overall, this research promises to provide versatile tools
for detailed investigations of C5 metabolism, expand our scientific understanding of C5 prenylation, and shed
light on potential therapeutic targets in the isoprenoid pathway.

Public health relevance
Project Narrative The proposed research involves the creation and application of chemical biology tools for detecting, quantifying, and manipulating the production of the five-carbon metabolites isopentenyl pyrophosphate (IPP) and dimethylallyl pyrophosphate (DMAPP). The research is relevant to public health because IPP and DMAPP are poorly understood, yet they form the central hub of isoprenoid metabolism, which is critical to many aspects of cellular physiology and has documented roles in cardiovascular disease, Alzheimer’s, cancer, cystic fibrosis, nonalcoholic fatty liver disease, and Zellweger spectrum disorder. Development of these chemical and biological tools will provide new avenues for understanding fundamental metabolism and the overall research objectives are in line with the NIH’s mission, as it has the potential to expand therapeutic interventions that will help reduce human suffering.